NWIC NARCH XI Administrative Core

Program Summary: NWIC NARCH XI Administrative Core
The purpose of the Northwest Indian College (NWIC) NARCH XI Administrative Core (AC) is to: (1) implement
a plan for establishing communication and collaboration among the different research projects and student
development and training initiatives; (2) facilitate IRB and Tribal approvals for the research projects and support
community-based participatory research (CBPR) and tribally-led initiatives to achieve health equity in American
Indian and Alaska Native (AIAN) communities; (3) centralize information sharing regarding funding opportunities
and resources for training and mentoring students, faculty and staff at NWIC and across projects and; (4)
coordinate contact with the NIH and maintain compliance in administrative and fiscal reporting. The AC will
maintain effective multi-directional communications across various stakeholder groups to ensure that the projects
are engaging tribal communities in ways that maximize equitable involvement and tribal control of data. The AC
will monitor NARCH projects and support local dissemination efforts and communication of research findings
back to tribal leaders, community members and policymakers to accelerate the translation of science into more
effective practices and services. Our proposed AC will leverage our successful partnerships with the University
of Alaska Fairbanks, Center for Alaska Native Health Research (CANHR) and the Northwest Washington Indian
Health Board (NWWIHB) to support partnership development and project activities with new research-intensive
partners; Washington State University, the University of Washington and the Western Interstate Commission on
Higher Education, and new tribal partners; Puyallup Tribe of Indians and Alaska Native Tribal Health Consortium.
The AC Core will support the success of each of the research projects and partnerships by (SA1) providing
tribally-led and controlled CBPR support, including assistance with DMSOAs and Tribal IRBs; (SA2) providing
administrative, fiscal and data support; (SA3) creating a centralized communication hub; and (SA4) developing
a plan to guide the evaluation of program activities and projects.